DF/HCC Kidney Cancer SPORE Administrative Core

Summary
The purpose of the Administration, Evaluation and Planning (Administrative) Core is to assure the coordination of the Dana Farber/Harvard Cancer Center (DF/HCC) Kidney Cancer SPORE components and to continue to provide oversight and leadership for the scientific, administrative and fiscal aspects of the SPORE. The Administrative Core allows for the provision of stimulating intellectual activities, organization of venues for planning future research through seminars and retreats, and the oversight of research and spending. Drs. McDermott and Kaelin, the SPORE Directors, are committed to the success of the SPORE and will personally monitor the progress of the Projects and Cores, oversee the Career Development and Developmental Research Programs, and oversee all other proposed activities. As both SPORE Directors and Leaders of the Kidney Cancer Program within DF/HCC, Drs. McDermott and Kaelin have the authority and resources to ensure the success of this SPORE. The Administrative Core of the DF/HCC Kidney Cancer SPORE will accomplish the goals of the SPORE by following six specific aims: 1) Monitor research progress and plan for the future, 2) foster collaborative research within and between SPOREs, 3) Integrate the DF/HCC Kidney Cancer SPORE into the structure of DF/HCC, 4) Provide necessary resources and fiscal oversight, 5) promote patient participation in Kidney Cancer research and treatment 6) Promote rapid dissemination of significant research findings and free and open communication and resource exchange between the DF/HCC SPORE and other institutions. As they have since early 2014, Drs. McDermott and Kaelin will provide the tools to foster collaborations between the institutions inside and outside of the SPORE, to leverage the considerable power of the SPORE in order to promote kidney cancer research.

Public health relevance
Narrative: The Administrative Core has been vital to the successful function of the SPORE. It has handled the scientific, administrative and fiscal responsibilities of the SPORE, maintained the expanded communication and educational efforts of the Program with newsletters and conferences and fostered additional research collaborations both within and outside DF/HCC. It has carried out an annual review of SPORE Projects and Cores, directed the selection of Career Enhancement Program Awardees and Developmental Research Projects and shepherded a thorough selection process for new Projects to be included within the initial SPORE competitive renewal and this competitive renewal application.